Divergence of Tactile Processing in the Dorsal Column Nuclei

Project Summary
The diverse range of sensory neurons that innervate the skin underlie our ability to perceive a remarkable range
of tactile stimuli and provide us with the capacity to manipulate objects, detect threats, and navigate our
environment. Despite the fundamental importance of our sense of touch, little is known about how recipient
neurons in the dorsal column nuclei (DCN) of the brainstem integrate primary sensory information, and how
processed information is then transmitted to the brain. Anatomical tracing studies have revealed multiple, non-
overlapping downstream targets of the DCN, the most prominent being the thalamus and inferior colliculus. As
the node between sensory information from the periphery and central somatosensory pathways, I hypothesize
that the DCN functions as a site of differential sensory integration to selectively tune output pathways to features
in the environment. My proposed experiments will address this hypothesis by characterizing the tuning properties
of DCN projection neurons that target the inferior colliculus and the thalamus, and by investigating how
responses are constructed by inputs from peripheral sensory neurons and inhibitory interneurons. This work will
overcome barriers in the field by combining novel brainstem recording methods with tools to manipulate the
activity of primary sensory neurons. In doing so, my proposal will yield insights into how the DCN processes
tactile information, and may also illuminate more general mechanisms by which the brain organizes sensory
information. Additionally, a fundamental understanding of early somatosensory processing will inform efforts to
develop neural prosthetics, as well as guide efforts to treat clinical cases where somatosensation is altered, such
as mechanical allodynia after peripheral nerve injury or hypersensitivity to light touch exhibited by individuals
with autism.

Public health relevance
Project Narrative Our sense of light touch underlies our ability to detect and discriminate a wide range of tactile stimuli, but the mechanisms by which the central nervous system integrates inputs from primary sensory neurons remain elusive. This proposal will advance our understanding of tactile perception through exploration of how somatosensory signals are organized within the dorsal column nuclei (DCN) of the brainstem for output to brain regions with distinct functions.